Assessment of Bone Composition Through a Novel Liquid/Solid State MRI Method

ABSTRACT Fragility fractures of the hip, spine or wrist affect 1.5 million Americans annually and are a common cause of pain, deformity and disability. Moreover, caring for these fracture patients costs nearly $10 billion annually. Based on the assumption that fragility fractures are caused by low bone mass, the World Health Organization (WHO) has identified individuals at risk for these fractures based on their areal bone mineral density measured by dual energy X-ray absorptiometry (DXA) compared to that of a normal young adult. However, fracture predictions based on areal bone mineral density have been shown to be neither sensitive nor specific. Whole bone strength is determined by the material properties of the bone tissue and its geometry. Areal bone mineral dnesity does not measure volumetric bone mineral density, the major determinant of bone stiffness and strength, and does not distinguish changes in bone tissue composition from changes in bone tissue volume and/or geometry. This distinction is important when diagnosing and treating skeletal diseases associated with low bone mass. While it is assumed that most fragility fractures are caused by osteoporosis, where the mineral composition of the bone tissue is normal, but the volume of bone tissue is decreased; 50% of postmenopausal women who fracture their hip and have no other cause for low bone mass, are deficient in vitamin D. Vitamin D deficiency can result in osteomalacia, where the mineral composition and bone tissue volume are both decreased. Indeed, of patients with low bone mass who fractured their hip, when their bone tissue was evaluated histologically, 13-33% were osteomalaciac. Correct assessment of the underlying causes of osteopenia, whether osteoporosis or osteomalacia, is important, as the treatment protocols for these two conditions are different, where osteoporosis may be treated with Bisphosphonates, PTH, Calcium, phosphate and vitamin D supplementation; whereas osteomalacia requires a more detailed evaluation, as the differential diagnosis is extensive, and each disease entity requires a somewhat different treatment approach. Since the treatment of osteoporosis and osteomalacia are different, it is imperative that the etiology of a patient's low bone mass be properly diagnosed. Therefore, we propose to develop a MRI based technique capable of measuring both bone tissue mineral and matrix composition and bone structure. To that end, we hypothesize that liquid+solid state MR imaging can be used to: differentiate metabolic bone diseases on the basis of bone tissue mineral composition and structural properties; and estimate the load capacity of normal and pathologic bones. Successful completion of this study will prove the feasibility of using this non-invasive and non-ionizing imaging technique to differentiate osteoporosis from osteomalacia, so that physicians may select appropriate treatment for at risk patients. This will provide an impetus to develop specialized MRI software and hardware that will make it possible to integrate liquid+solid state MR imaging routinely into clinical scanners or specialized peripheral MRI scanners that can be used for mass screening of at risk patients. The immediate career goals of the applicant are to gain expertise in the field of liquid and solid state MR imaging, generate preliminary results in the proposed project, contribute to the body of knowledge, obtain foundation grants to continue work, and move towards independence as a scientist and a principal investigator. The applicant will be supervised closed by the mentor and the co-mentor over the course of the study via informal regular meetings and formal meetings every two months to assess the applicant's progress along the project timeline. Additionally, the applicant will receive hands on and theoretical training on MR imaging, and training in bone biology and pathophysiology. His training will be augmented by attending various seminars, grant writing workshops and leadership development workshops. An advisory committee made up of experienced scientists in the field (Drs. Boskey, Bouxsein, Glimcher and Neer) will monitor the applicant's progress through meetings every six months and will be tasked with assessing the applicant's readiness to move on to the independent phase of the award, based on the applicant's fulfillment of the following criteria: independent and solid foundation in MR imaging principles, coil building and tuning, bone biology and pathophysiology; progress in research project as per study timeline; submission of three manuscripts by the end of the mentored phase; submission of a foundation award proposal based on research work; and ability to think independently and plan out a R01 level grant proposal. The applicant will be required to design and submit a R01 grant at the beginning of year two of the independent phase to assure funding continuity. The applicants' career goal is to develop as an independent musculoskeletal investigator with expertise in bone biomechanics and imaging to achieve the ultimate public health aim of helping to reduce fragility fracture risk associated with skeletal pathologies and their impact on patients and the health care system. While DXA imaging has been a useful tool to raise awareness and assess fragility fracture risks in individuals at risk, the inherent limitations associated with this modality and the recent advances in skeletal solid and liquid state MR imaging have provided a fresh impetus to develop the next generation of diagnostic systems capable of accurately identifying the underlying cause(s) of altered skeletal states.

Public health relevance
PROJECT NARRATIVE The ultimate goal of this work is to establish liquid+solid state MR imaging as a method to perform a "virtual bone biopsy" to non-invasively assess the organic matrix and inorganic mineral composition of bone, in order to diagnose metabolic bone diseases, predict fracture risk and guide treatment. __SpecificAimsTextDelimiter__ 10. SPECIFIC AIMS One and a half million Americans suffer from fragility fractures of the hip, spine or wrist subjecting them to pain, deformities and disability1,2, and resulting in health care costs in excess of $10 billion annually3. Based on the assumption that fragility fractures are caused by low bone mass, the World Health Organization (WHO) has defined individuals at risk for these fractures based on their areal bone mineral density (aBMD, g.cm-2) relative to that of a normal young adult, as measured by dual energy X-ray absorptiometry (DXA). However, fracture predictions based on aBMD have been shown to be neither sensitive nor specific4-8. aBMD, a 2D projection of a 3D construct, is not representative of the volumetric bone mineral density (vBMD, g.cm-3) and is incapable of distinguishing between changes in the two main determinants of bone strength, its material and geometric properties9. This distinction is essential for the proper diagnosis and treatment of skeletal diseases associated with low bone mass. While it is assumed that most fragility fractures are caused by osteoporosis, where decreased bone volume is viewed as the main culprit; 50% of postmenopausal women who fracture their hip and have no other cause for low bone mass, are diagnosed with vitamin D deficiency10,11. Vitamin D deficiency can result in osteomalacia, where both bone mineral composition and volume are decreased. Indeed, up to 33% of patients with low bone mass who have suffered a hip fracture have been diagnosed with osteomalacia (hypo-mineralized osteoid) upon subsequent histologic evaluation12-16. Thus, accurate assessment of the underlying causes of osteopenia, whether osteoporosis or osteomalacia, is important, as the treatment protocols for these conditions are very different. Therefore, we propose to develop a new non-ionizing approach capable of measuring bone mineral and matrix composition and structure17 to properly quantify changes in bone material and geometric properties altered by different pathologic conditions. Toward this end, our group has demonstrated that the organic matrix component of bone (¿MAT) can be measured using water and fat suppressed proton magnetic resonance (MR) imaging (WASPI)18 (which cannot otherwise be measured non-invasively), and that the mineral component of bone (¿MIN) can be measured using 31P solid state MR imaging (31P SMRI)19,20. Further, our group and others21-23 have established that bone volume fraction (BV/TV), trabecular microstructure and cross-sectional bone geometry can also be measured using 1H liquid state MR imaging. Thus, we hypothesize that combined liquid (1H) and solid (WASPI and 31P SMRI) state MR imaging can be used to (a) differentiate metabolic bone diseases on the basis of bone tissue mineral composition and structural properties; and (b) estimate the load capacity of normal and pathologic bones. Our ultimate goal is to establish liquid+solid state MR imaging as a method to perform a "virtual bone biopsy" in humans to non-invasively assess the organic matrix and inorganic mineral composition of bone to diagnose skeletal diseases, predict fracture risk and guide treatment. However, first we must prove that liquid+solid state MR imaging can be used to evaluate the range of metabolic bone diseases that may be encountered clinically using well established rat models in a controlled environment. We understand that rat bones undergo minimal secondary remodeling. Therefore, they are only used for basic validation of techniques outlined here and not as a substitute for human bone/pathology. 10.1 Mentored Phase Aims Therefore, as part of the mentored phase of this proposal, we propose to evaluate two rat models that exhibit a range of bone diseases that differentially affect cortical and cancellous bone tissue composition and structure. These rat models will be used to parametrically evaluate the ability of liquid+solid state MR imaging to assess bone tissue physical properties and to predict the mechanical behavior of normal and osteopenic (osteoporosis and renal osteodystrophy) bone. Aim I: Test the hypothesis that liquid+solid state imaging can measure bone tissue physical properties for normal or pathologic bone from rat models. We will validate that liquid+solid state MR imaging can accurately measure ¿MIN, ¿MAT, % min, BV/TV and vBMD for bone samples extracted from normal rats and rat models of osteoporosis (normal matrix mineralization, markedly decreased BV/TV) (27) and renal osteodystrophy (hypo-mineralized matrix, decreased BV/TV) (28). Agreement between tissue properties measured using liquid and solid state MRI and those measured directly via gravimetry, micro-computed tomography (μCT), FTIR imaging and histology will be assessed. <<Data from animal experiments will be used as a pattern classification training set to establish differences between the abovementioned disease states based on ¿MIN, ¿MAT, % min, BV/TV and vBMD.>> Aim II: Test the hypothesis that the load capacity of normal and pathologic bone can be predicted from bone tissue physical properties and cross-sectional geometry measured by liquid+solid state MR imaging. We will validate that liquid+solid state MR imaging can be used to predict the load capacity for cortical and cancellous bone samples extracted from normal rats and rat models of metabolic bone disease that produce either osteoporosis or renal osteodystrophy by calculating the tensile, compressive and torsional rigidities from the physical properties of the bone tissue and the cross-sectional geometry obtained on serial, transaxial MRI images. The relationships between tensile, compressive and torsional rigidities calculated from MRI and the failure loads and torque measured directly will be assessed. 10.2 Independent Phase Aims Upon validation of this technique in animal models, it is imperative that we demonstrate the feasibility and reproducibility of measuring bone mineral and matrix composition simply and conveniently in patients thought to be at risk for fragility fractures; thereby, facilitating the initiation of appropriate interventions to prevent the occurrence of fractures. Therefore, as part of the independent phase of this project, I propose to evaluate the distal radius of patients who have sustained a hip fracture using liquid+solid state MR imaging and compare these non-invasively measured bone tissue mineral/matrix composition and structural properties to those measured directly at the resected femoral head in the same hip fracture patients. Aim I: Test the hypothesis that liquid+solid state MR imaging can accurately and reproducibly assess bone tissue physical properties in human cadaveric bone. Validate that liquid+solid state MR imaging can accurately measure ¿MIN, ¿MAT, % mineralization, BV/TV and vBMD of human cadaveric radii and proximal femur. <<The pattern classifiers established from the animal study will be used to differentiate between disease states in the human specimens enrolled as part of the independent phase of the study.>> Twenty four cadaveric forearms (with soft tissue envelope intact) and proximal femora from the same cadavers will undergo liquid+solid state MR imaging. All bone segments evaluated by MR imaging will be excised and undergo micro-computed tomography (μCT) imaging to assess BV/TV and vBMD, and gravimetric measures to assess ¿MIN, ¿MAT and % mineralization. The bone cores excised from these samples will be embedded in polymethylmethacrylate and sectioned, to assess bone mineral content and composition (phosphate vs. carbonate) and matrix content via Fourier Transform Infrared Spectroscopy (FTIR) and evaluate extent of osteoid mineralization via calcified tissue histology. Agreement between bone tissue properties measured using liquid and solid state MRI and those measured directly using gravimetric methods, micro-computed tomography (μCT), FTIR imaging and histology will be assessed. Further, the correlation between bone tissue properties measured at the distal radius and the proximal femur will be established. A subset of 10 cadaveric forearms will be used to evaluate the repositioning errors and the static reproducibility errors associated with the inherent stability of the system and the signal to noise ratio. Aim II: Test the hypothesis that liquid+solid state imaging measured at the distal radius in-vivo can differentiate osteoporosis from osteomalacia in patients with hip fracture. The proximal femur will be obtained from hip fracture patients treated by total or hemi- hip arthroplasty. Prior to discharge from the hospital, these patients will undergo liquid+solid state MR imaging performed of the distal radius of their dominant hand using a specialized coil in a clinical scanner. Trabecular bone core specimens will be obtained from the resected femoral heads of these patients and evaluated by liquid+solid state imaging, μCT imaging and gravimetric analysis. These core specimens will be embedded in PMMA and sectioned for Fourier Transform Infrared Spectroscopy (FTIR) and calcified tissue histology to measure the bone tissue mineral and matrix content and composition directly. Laboratory tests to assess serum calcium, phosphate, protein, PTH, vitamin D3, thyroid function and renal function will be obtained to evaluate metabolic bone diseases that cause osteomalacia. Agreement between bone tissue properties measured in vivo using liquid+solid state MRI at the distal radius compared to those properties measured directly at the resected femoral head/neck fragment using liquid+solid state MR imaging, quantitative μCT, FTIR, gravimetry and histology will be assessed. Successful completion of these aims will prove the feasibility of using liquid+solid state MR imaging to differentiate osteoporosis from osteomalacia, so that physicians may select appropriate treatment and preventative measures for at risk patients. This study will provide the impetus needed to develop specialized MR imaging software and hardware to routinely integrate liquid+solid state MR imaging into existing clinical scanners and to design and implement the next generation of cost effective and mobile MR scanners of peripheral anatomic sites to be used for mass screening of at risk patients at urban and rural outpatient settings in developed and developing nations.